Reducing disparities in alcohol use disorder treatment in underserved areas

PROJECT SUMMARY/ABSTRACT
Reducing the prevalence of alcohol use disorder (AUD) is a public health priority in the US as highlighted in
Healthy People 2030. Although pharmacological and behavioral treatments can reduce alcohol-related harms,
a large unmet need for AUD treatment exists. The unmet need can be attributed to several factors, including
the ongoing shortage of mental health workforce. In 2022, over 148 million (45%) of Americans resided in
mental health professional shortage areas (MHPSAs), facing barriers to access to AUD treatment.
To attract more clinicians to MHPSAs, policymakers have launched many programs, including the National
Health Service Corps (NHSC). Since 2009, federal investment in the NHSC has experienced a significant
surge, resulting in the NHSC clinician workforce more tripling by 2022. Compared with other types of NHSC
clinicians (e.g., primary and dental care clinicians), the NHSC mental health workforce experienced the largest
growth since 2009. However, no study to date has evaluated the potential effect of the NHSC expansion on
disparities in AUD treatment across geographic areas. We hypothesized that the substantial growth of mental
health workforce brought about by the NHSC expansion reduced disparities in AUD treatment and outcomes
between MHPSAs and other areas. Further, we posited that the effects of the NHSC expansion on AUD
treatment disparities differ by population groups and clinician types given the facts that people with lower
socio-economic status dominated MHPSAs and that the growth of the NHSC’s workforce varied by clinician
type (e.g., psychiatrists, clinical psychologists, clinical social workers, and clinical counselors).
This proposed project will examine these hypotheses and fill the gap in the literature. Specifically, the
project aims to assess the effect of the NHSC expansion on disparities in AUD mortality, unmet need for AUD
treatment, and utilization and costs of alcohol-related emergency department visits and hospitalizations. In
addition to geographic disparities between MHPSAs and non-shortage areas, the project will examine effect
heterogeneity of the NHSC expansion across population groups and clinician types. We will use multiple large,
national data files. To analyze the data, we will take two complementary approaches, including a difference-in-
differences method and an instrumental variable approach, to generate rigorous quasi-experimental evidence
about the impact of the NHSC expansion on AUD treatment disparities.
By focusing on health workforce issues in underserved areas, the proposed study is highly relevant to
NIAAA’s PAR-23-185, which lists workforce-related barriers to access to AUD treatment as a specific area of
interest. The study findings will have important implications for policy decisions related to future directions for
the NHSC and further reducing disparities in AUD treatment and outcomes.

Public health relevance
PROJECT NARRATIVE The severe shortage of mental health clinicians plays a crucial role in the unmet need for alcohol use disorder treatment, creating an urgent and critical public health issue in the United States. To mitigate the clinician shortage problem, Congress has significantly expanded the National Health Service Corps (NHSC) since 2009, which is the largest public policy intervention to attract clinicians to practice in mental health professional shortage areas. This proposed project aims to examine whether the NHSC expansion reduced the unmet need for alcohol use disorder treatment and improved disparities in alcohol use disorder treatment and outcomes in mental health professional shortage areas.